Institutional Career Development Core, KL2 Scholars Program

Contact PD/PI: LARSON, RICHARD S Inst-Career-Dev-001 (300) The goal of the Institutional Career Development program (KL2) is to continue building a cohort of independent, innovative CTR scientists at UNM HSC. In CTSC 1.0 & 2.0, we provided focused, effective mentoring for scholars, who in turn were successful in conducting research, publishing, and obtaining independent extramural funding. Their accomplishments propelled their careers and helped them attain personal goals in CTR and academic leadership. All 14 KL2 scholars continue to conduct research and have collectively garnered over $14M in NIH funding. By cultivating scholar careers, UNM HSC benefits enormously through an expanded CTR faculty base. Our KL2—uniquely structured to recruit nationally for new scholars to expand our research capacity—has mentored faculty scholars in eight UNM HSC departments, providing broad institutional support. The long-term goal of KL2 is to build a legacy of highly skilled, successful translational scientists with a team-science mindset to address the significant health problems of New Mexico, the region, and nation. Our objective is to foster research abilities, writing skills, and funding success of junior faculty scholars through dedicated mentorship and career development. By supporting and retaining successful CTR scientists, KL2 demonstrates UNM CTSC’s importance in catalyzing CTR career development, thereby strategically increasing CTR capacity for all UNM HSC departments. Our rationale is that, by building on our already successful KL2, we will continue to develop the next generation of accomplished translational scientists. CTSC 3.0 will meet our overarching goal through these specific aims: 1) Through the KL2 mechanism, expand the base of active and impactful CTR at UNM HSC; 2) Expand and evolve the CTR mentoring environment at UNM HSC; 3) Employ personalized pathways to flexibly implement scholar career development strategies; and 4) Implement a comprehensive evaluation process with formative and summative components for assessment of KL2 scholars, mentors, and the KL2 program. Our expected outcome is enhanced capacity to conduct CTR on the most important problems facing our state, region, and nation. Such outcomes are expected to have an important, long-term positive impact on the UNM HSC CTR workforce, creating a generation of highly trained CTR scientists who significantly accelerate the translation of discovery into beneficial health impacts.